Enhancing the Care Continuum for Veterans Who Inject Drugs Using Harm Reduction Approaches

Project Goals: The long-term goal of this Innovation Project is to implement comprehensive harm reduction
services in VA that will reduce high and unacceptable rates of fatal overdoses and prevent viral (HCV, HIV)
and invasive bacterial (sepsis, endocarditis) infections associated with the rise in opioid and other drug
injection among Veterans. The Phase I goal is to work collaboratively with multiple VA Medical Centers
(VAMCs), VA operational partners, community agencies and Veterans to develop comprehensive harm
reduction “bundles” that are adaptable for use in different service lines (i.e., inpatient, outpatient) and
geographic areas (i.e., urban, suburban, rural). These “bundles” will include options for accessing and
providing sterile syringes, Narcan and overdose prevention education, skin cleaning education, and
recommendations for infectious disease screening and other prevention resources. We will develop a Harm
Reduction Community of Practice to collaboratively explore and address social, logistical and policy barriers to
implementing harm reduction approaches in VA, develop harm reduction delivery models that include
recommendations for who, when and how “bundles” are provided, and develop supporting resources (e.g.,
provider training, model community contracts) for implementation of harm reduction approaches). Our second
goal is develop an implementation study for Phase II, including identification of participating VAMCs,
implementation strategies, and outcomes. The Long-term Aim of the Phase II Project is to conduct a multi-
site implementation study assessing the impact of providing harm reduction services, including access to
sterile syringes, on Veterans’ health outcomes, VAMCs financial burden of care, and the culture of healthcare
for Veterans who inject drugs. Innovation: Despite the strong and overwhelming evidence-base for harm
reduction approaches, healthcare systems in the U.S. have been slow to adopt them into practice. Recent
changes in federal policies and a 2018 National Ethics in Healthcare opinion allow healthcare agencies to
develop comprehensive harm reduction services in the interest of public health. Continued restrictions on the
use of federal funding to purchase sterile syringes require partnering with state or community agencies to
support access. This creates opportunities to bridge care for vulnerable and hard-to-reach Veterans and assist
them in accessing needed resources to protect their health and engage in self-care. If successful, VA will be
among the first healthcare systems in the U.S. to offer these critical services to IVDUs. Impact: Increasing
access to sterile syringes, Narcan and other harm reduction resources will prevent fatal overdoses and costly
viral and bacterial infections. If implemented in accordance with principles of patient-centered care, it will also
help reduce stigma associated with IVDU and engage this vulnerable population of Veterans in VA care.
Phase I Accomplishments include the formation of a robust Harm Reduction Community of Practice that
allows us to work collaboratively across disciplines and setting types to develop reasonable and feasible harm
reduction “bundles” that can be implemented and tested in Phase II. This work includes addressing real and
perceived policy barriers to implementing comprehensive harm reduction approaches in VA, socio-cultural
challenges associated with stigma of injection drug use, development of guidance for how to partner with
community agencies to access sterile syringes and options for making them available to Veterans, and
implementation resources (e.g., training materials, CPRS consult templates, example community contracts).
Next Steps: Findings from the Phase II multi-site study will inform refinements to the Harm Reduction
Implementation Package, which will be disseminated to VAMCs across the country and improve the quality
and responsiveness of care for Veterans with opioid dependency.

Public health relevance
Project Narrative Not Required